Taxonomics Methods Using DNA

The project started when Dr. Spouge was invited to analyze data for the 2009 Edinburgh Conference Selecting Barcode Loci for Plants, a meeting of the Plant Working Group within the Consortium for the Barcode of Life. Later, Dr. Spouge performed a similar data analysis for the Fungal Barcode Working Group in Amsterdam in 2011. In collaboration with Dr. Martin, he has used DNA barcodes to analyze fungal taxonomy in South-East Asia and Spain. Implementations of his analysis are publicly available in user-friendly programs, updated to permit barcode researchers to replicate Dr Spouge's analyses on their own data. Dr Martin has actively tested the web tools. The collaboration is also producing statistical methods for the objective comparison of methods of taxonomic classification, notably GenBank annotation and expert classification. Dr Martin is applying the methods and tools in the fungal Genus Ramaria.